Georgia Department of Agriculture - NARMS

NARMS - Project Summary/Abstract
The Georgia Department of Agriculture (GDA) is the state agency responsible for regulation of
food manufactured facilities and retail establishments. GDA Laboratories (Lab) are the primary servicing
laboratories for regulatory programs and are focused on food analysis for chemical and microbiological
contaminants. Since 2011, GDA has pursued FDA grants and cooperative agreements to improve and
harmonize our state regulatory and testing capability. Through these grants the Lab achieved
accreditation to ISO/IEC 17025 which allows our regulatory agencies to perform contractual work on
behalf of FDA. Since GDA is Georgia’s regulatory authority over food retail establishments, the agency
has inspectors positioned all throughout the State of Georgia. These inspectors are trained to collect
samples and return them to our lab for testing that can support regulatory enforcement.
Since GDA already has infrastructure designated for sample collection at retail establishments
and the analysis of microorganisms by the Lab, this award opportunity NARMS (National Antimicrobial
Resistance Monitory System) has been a seamless fit into GDA over the past four-year project period.
In summary, GDA inspectors will collect the samples and send them to the Lab via routine
protocols. The Lab will screen the samples for the target organisms required by the NARMS program
and those outlined in the Funding Opportunity Award (FOA). The Lab will utilize methods described in
the project protocol. Isolates showing typical characteristics will be further examined and confirmed or
sent to FDA for further evaluation. Whole genome sequencing will be conducted by GDPH Lab in a
previously established partnership.
The Lab has developed and demonstrated successful relationships with their regulatory partners
and the GDPH Lab, which should indicate its ability to fulfill this objective. The Lab also routinely
performs thousands of microbiological analyses on retail food samples annually. If awarded the renewal
of the NARMS cooperative agreement, GDA will be capable of enhancing and strengthening
antimicrobial resistance surveillance data. This in turn can be used to inform public health stakeholders
about populations of resistant strains and if current policy and practices are adequate for overall safety
of consumers.

Public health relevance
NARMS Project Narrative The Georgia Department of Agriculture’s Labs will work with their regulatory partners to collect targeted food sample and test them for the selected microbes identified in the NARMS FOA. These samples will be collected throughout the State of Georgia (or per FDA directive) from retail establishments to ensure data collected is representative of each region. In addition, assistance from Georgia Department of Public Health (GDPH) Labs will perform any necessary Whole Genome Sequencing. Isolates and data collected from this project will be forwarded to FDA so that they can combat antibiotic resistance threats in food commodities.